A Rapid and Comprehensive Approach for Clinical Genomic Profiling in Lung Cancer

ABSTRACT
The long-term goal of this project is to advance precision medicine by developing a simple, rapid, and
comprehensive approach to molecular diagnostic testing that can be easily performed on any cancer subtype.
In lung adenocarcinoma and many other solid tumor types, optimal treatment relies on the identification of
specific genomic alterations. These include single nucleotide variants and small insertions and deletions, as well
as larger copy number alterations and chromosomal translocations. Currently, clinical testing for these mutations
requires multiple assays and significant amounts of tissue so that both DNA and RNA can be obtained for
analysis. As a result, many samples fail or simply cannot be tested. At our cancer center 38% of lung cancer
patient biopsies sent for comprehensive molecular evaluation either fail or result in incomplete results. More
robust and streamlined diagnostic methods are therefore needed to provide truly comprehensive mutational
profiling for all cancer patients. We have developed a novel approach for whole-genome sequencing
(ChromoSeq) that provides rapid, unbiased evaluation of all mutation types in a single assay. ChromoSeq
leverages recent advances in high-throughput sequencing methods to deliver a complete genomic profile in as
little as 3 days using minimal DNA input. We have previously shown that ChromoSeq can provide rapid
comprehensive genomic profiles from blood or marrow of patients with myeloid malignancies and that
ChromoSeq has increased sensitivity to detect clinically significant genomic alterations compared to
conventional methods. However, obtaining similar performance from solid tumors with limited amounts of
degraded DNA typically obtained from formalin-fixed paraffin-embedded (FFPE) tissue biopsies is challenging.
We hypothesize that with substantial methodologic pre-analytic improvements and rigorous clinical validation
testing, ChromoSeq can also be used for the comprehensive genomic profiling of solid tumors. In this application,
we propose to measure and optimize DNA changes that occur during pre-analytic tissue processing of routine
clinical biopsies (Aim 1) and then establish the clinical performance of the assay using retrospectively and
prospectively collected patient samples (Aim 2). These Aims will be performed in a CLIA-licensed, CAP-
accredited laboratory with the overall objective of producing a CLIA-compliant assay for future use in clinical
studies and to improve the diagnosis and treatment of patients with lung cancer. Tools and protocols developed
in this application will enable other laboratories to benefit from this simplified approach to cancer genomic
profiling.

Public health relevance
Genomic profiling of solid tumor samples is now essential for the diagnosis and clinical management of many cancer types including lung adenocarcinoma, however current approaches for detecting the full spectrum of cancer mutations involve complicated testing methods and often fail due low specimen quantity or quality. In this proposal, we aim to optimize a rapid and robust whole genome sequencing method, ChromoSeq, that provides a genome-wide profile of all cancer mutation types from commonly available fixed biopsy material, and then validate its clinical performance for patients with lung adenocarcinoma.